University of Alabama at Birmingham's Diabetes Research Center

PROJECT SUMMARY / ABSTRACT ADMINISTRATIVE CORE
The Administrative Component will assure the effectiveness of the DRC in meeting the center’s stated goals
and specific aims. This component includes the Administrative Core, the Pilot & Feasibility Grant Program, and
the Enrichment & Training Program. The DRC will be directed by W. Timothy Garvey MD, assisted by
associate directors Drs. Barbara Gower and Anath Shalev. The Director and Associate Directors will join other
key DRC faculty in comprising the DRC Action Committee, Drs. Stuart Frank, Scott Ballinger, Douglas
Moellering, Tim Nagy, Andrea Cherrington, and C. Beth Lewis. The ultimate goal of the Admin Core is to
assure the growing vitality of an intellectual community and a highly productive research program in diabetes,
by effective deployment of DRC resources, for the benefit of our members, patients, trainees, and community.
Operationally, the Core will assure productivity and effectiveness of DRC activities including the biomedical
and translational research core facilities (REDOX Biology, Animal Physiology, Human Physiology,
Interventions & Translation), a pilot & feasibility grant program that promotes research progress of promising
investigators and innovative lines of investigation, and an enrichment program that advances the DRC as an
intellectual community, promotes interactions and discussions regarding new discoveries and concepts,
provides a forum for the formation of multidisciplinary collaborations, and establishes a dynamic educational
environment for training and career development. The Admin Core will be responsible for the managing
membership, the network of DRC communications and website, bookkeeping, progress reports, quality control
and evaluation, interface with NIH/NIDDK, assurance of responsible fiscal management and regulatory
compliance, and will obtain and implement recommendations of Internal and External Review Committees.
Over the 9 years of UAB DRC existence, the Admin Core has overseen a progressive increase in
members, publications, research grant dollars, recruitment of new faculty, and development of new research
areas such as islet cell biology that have enhanced and broadened the scope of our diabetes research. The
DRC has united areas of research excellence under the umbrella of diabetes and cardiometabolic disease and
established a cohesive intellectual community. The Admin Core has facilitated the evolution of the DRC by
initiating new core services to meet investigator needs, an enrichment program that introduces new ideas and
scientific discoveries, career development of mentored members, and development of new areas of research
excellence. Thus, the DRC will continue to exert a pronounced impact on diabetes research excellence at
UAB and we are confident that further evolution and growth will be achieved over the next 5 years.